Quantifying replication dynamics to predict clonal evolution and drug sensitivity in cancer cells using single-cell whole genome sequencing

Project Summary
Recent developments in single-cell whole genome sequencing (scWGS) such as direct library preparation
(DLP) have enabled rich interrogation into the genomic diversity of hard-to-treat breast and ovarian cancers.
Studies from the Shah Lab have used DLP to infer clonal fitness from time-series sampling and assess the
impact of mutational processes on structural genomic plasticity; however, these studies only looked at
genomes from non-replicating cells. The proposed project leverages S-phase cells captured by DLP to
prospectively predict clonal fitness and chemosensitivity using data from a single time point (Aim 1) and,
separately, to measure the contribution of aberrant replication towards the accumulation of copy number
aberrations (CNAs) across cancers of various genetic context (Aim 2). For my first aim, I propose a
computational framework for assigning S-phase cells to phylogenetically inferred clones and subsequently
calculating the S-phase fraction (SPF) within each clone. For my second aim, I propose a Bayesian model to
estimate single-cell replication timing in a manner that is robust to somatic CNAs. I hypothesize that SPF will
be a proxy for proliferation rate and thus high SPF clones will have higher treatment-naïve fitness and
sensitivity to platinum-based chemotherapy than their low SPF counterparts. I further hypothesize that
heterogeneous replication timing will correlate with the extent of replication stress in a particular DLP sample.
Investigating both hypotheses will be important for extending the clinical utility of DLP since identifying which
clones will respond to chemotherapy will help guide clinical management and identifying the presence of
replication stress will help stratify patients for next-generation targeted therapies, such as ATR inhibitors, that
selectively kill cancer cells undergoing replication stress. In summary, the proposed computational methods
will extend the utility of scWGS technologies which capture replicating cells by connecting replication dynamics
to clonal fitness, replication stress, CNA patterns, and drug sensitivities in genomically unstable cancers.

Public health relevance
Project Narrative Genomically unstable cancers such as breast and ovarian cancers are hard to treat due to their ongoing accumulation of copy number aberrations (CNAs) which leads to intratumoral heterogeneity. New single-cell whole genome sequencing (scWGS) methods such as direct library preparation (DLP) can profile CNAs at single-cell resolution, providing new insights on mutational processes and clonal competition within tumors. While previous scWGS analysis has focused on non-replicating cells, this proposal aims to use the S-phase cells captured in DLP libraries to predict clonal proliferation rates and determine the role of aberrant DNA replication across cancers of varying mutational processes.